Traumatic axonopathy and Alzheimer tau propagation

PROJECT SUMMARY
In this application we explore the role of axonal injury in the propagation of protein aggregates in the CNS, based
on the known association between traumatic brain injury (TBI) and neurodegenerative disease. Emphasis here
is on the microtubule-associated protein tau, which undergoes a number of modifications and then aggregates
in hallmark deposits in the so-called tauopathies, neurodegenerative diseases that include Alzheimer’s disease
(AD) and chronic traumatic encephalopathy (CTE). Specifically, we propose that axonal pathology and tauopathy
interact and that the integrity of CNS axons is a key independent factor influencing propagation of tau
hyperphosphorylation or aggregation across interconnected brain regions. Our proposal is founded on pilot data
confirming findings from other groups that we can generate extensive tauopathy in forebrain and some brainstem
circuits after injections of fibrillar tau extracted from AD brains (AD-tau) in cortex and hippocampus. More
importantly, we have recently established the role of sterile alpha and HEAT/Armadillo motif containing 1
(SARM1), the main trigger of Wallerian axonal degeneration, as a key instructive signal for traumatic axonal
breakdown in the CNS and identified small CNS-penetrant molecules that may interfere with SARM1-related
signaling. Our proposal is organized in two specific aims. In Aim 1 we explore whether traumatic axonal injury,
by degrading axon structure, accelerates/expands the tauopathy induced by seeding the mouse brain with AD-
tau to form pathological (hyperphosphorylated/aggregated) tau signatures in host brain circuits. Here we propose
that axonal injury caused by the central fluid percussion model of diffuse TBI will facilitate the propagation of tau
pathology in mice inoculated in the hippocampus and neocortex with tau seeds extracted from AD brains. In Aim
2 we explore the role of the axonal degeneration signal SARM1 in the systems propagation of tau pathology
away from the initial AD-tau inoculation sites and in the related neuroinflammation. Here we propose that by
deleting SARM1, thus protecting axons in the same diffuse TBI model as Aim 1, we may ameliorate the severity
and spread of baseline or injury-accentuated tauopathy and the related neuroinflammation and, eventually,
suppress neurodegeneration/cell death. To achieve the previous aims, we use a complement of anatomical and
genetic tools including SARM1 knockout mice and high-resolution neuropathology including, among else, brain
clearing methodologies such as CLARITY and SHIELD and electron microscopy. Once we establish SARM1 as
a relevant molecular target in tauopathy, then we will be in position to confirm these findings with more precise
gene editing using CRISPR methodologies available in our lab and small molecules that interfere with SARM1
signaling. In concert, by exploring the role of SARM1 in the propagation of aggregation-prone or aggregated tau,
we pursue a new approach in understanding the mechanisms of neurodegenerative tauopathies, including AD
and CTE. Because SARM1-related signaling may be soon tackled with small molecules, we also identify
molecular targets with substantial therapeutic potential.

Public health relevance
NARRATIVE Neurodegenerative tauopathies like Alzheimer’s disease are characterized by the formation of deposits of abnormal (fibrillar) tau protein. Fibrillar tau is formed and then progressively spreads along brain connections. In this project we propose that injury to the axons, the long processes that neurons use to connect with each other, contributes to the spread of fibrillar tau and thus facilitates the neurodegenerative process; we also propose that targeting SARM1, an enzyme that triggers axonal breakdown, may allow us to develop treatments that prevent spread of abnormal tau and thus modify the progression of disease.